LEARRN: Techniques Development Component

PROJECT SUMMARY
LeaRRN’s mission is to improve the quality, outcomes and value of rehabilitation care by fostering stakeholder-
partnered research within and across Learning Health Systems (LHS). As part of the LeaRRN, the overarching
objective of the Administrative Oversight Component is to catalyze and champion the mission, goals and
activities of LeaRRN. This Component will be led by the experienced leadership team of Dr. Linda Resnik, PT,
PhD, (PI), and Dr. Mary Slavin, PT, PhD (Investigator-BU). Their work will be guided by an Executive
Committee (EC) and an independent national advisory board. The Administrative Oversight Component will
provide scientific leadership and administrative oversight of all LeaRRN activities, identifying, coordinating and
distributing resources, and facilitating communications and collaboration across all Components. The
Administrative Oversight Component will evaluate and document the ongoing effectiveness of LeaRRN and
fulfill all reporting requirements. This Component will also provide day-to-day administrative support, identifying
and coordinating needed resources and distributing those resources back out to the Components. It will
prioritize resource allocation and provide financial oversight, administering the budget and overseeing
expenditures in a manner that maximizes shared resources. The Administrative Oversight Component, with
input from the Executive Committee, will be responsible for evaluation of all LeaRRN programs and activities
using a formal evaluation plan. LeaRRN’s Executive Committee will be chaired by Dr. Resnik. Members will
include the Principal Investigators and Co-PIs of all other Components. The Administrative Oversight team will
convene an Independent Advisory Board (IAB) to oversee the functioning of the Components and achievement
of LeaRRN’s objectives. The IAB will provide guidance to insure that LeaRRN’s activities are responsive to the
needs of the rehabilitation community. The successful achievement of the LeaRRN’s aims will be facilitated by
its strong leadership team, and existing effective collaborations between investigators and institutions.
LeaRRN’s Administrative Oversight Component will be based within the Brown University School of Public
Health’s Center for Long-Term Care Quality & Innovation (Q&I Center). The Q&I Center is a component of the
Center for Gerontology and HealthCare Research, a nationally-prominent health services research program
that studies the diverse health and social service needs of older adults and those with chronic illnesses. The
Administrative Oversight Component will be supported by a dedicated Program Manager, a Program Assistant
based at Boston University, and the rich research administrative infrastructure of Brown University’s Center for
Gerontology and Health Care Research.